Spatiotemporal Health Analytics: Geospatial connections to toxicology

Within environmental health sciences, there is an ever-growing need for methodological development and applications of spatiotemporal models that can handle the large, complex data and interdisciplinary challenges. Towards this end, the Spatiotemporal Health Analytics Group (1) elucidated novel health effects from complex air pollution mixtures on under-studied skin autoimmune diseases, (2) developed a proof-of-concept study on quantifying the risk of exposure to environmental chemical mixtures via a common molecular target with an application of modeled air pollutants and CYP1A1 mRNA transcription up-regulation, and (3) initiated the development of statistical methods to improve gene regulatory network estimation with Gaussian processes and mechanistic gradient matching.